Mechanisms of Loss, Recovery and Disorders of Consciousness

PROJECT SUMMARY
The long-term objective of this proposal is to understand cortical mechanisms underlying loss, recovery, and
disorders of consciousness. We have previously characterized neural activity associated with different stages
of general anesthesia and sleep. Each of these stages is composed of distinct states of arousal and
awareness, such as fluctuations between dreaming and unconsciousness. Finding neural underpinnings of
these processes is necessary for understanding the neural basis of consciousness. This proposal takes
advantage of the unique opportunity to directly record from the human brain in neurosurgical epilepsy patients.
We will use intracranial electroencephalography (iEEG) to identify signatures of unconsciousness and
distinguish it from three different states of consciousness: waking consciousness, drowsiness, and dreaming.
The scientific premise of this project is that the biomarkers of clinically relevant changes in arousal and
awareness share common features, generalizing beyond specific conditions that cause them. Our work to date
has identified putative biomarkers that show promise for distinguishing states of arousal and awareness. These
biomarkers include region-specific changes in cortical responses to unexpected sounds and speech, and in
patterns of cortical connectivity. Using innovative computational approaches applied to data obtained using
electrical stimulation and recording of ongoing brain activity at rest, we will track rapid transitions in cortical
network configurations. Characterizing these rapid transitions will enable us to identify clinically relevant
changes in arousal and awareness.
Our multimodal approach combines high resolution iEEG with computational modeling, electrical stimulation
tract tracing, conventional scalp-recorded EEG, and magnetic resonance imaging in overlapping sets of human
subjects. We will find reliable biomarkers that can identify distinct states of consciousness that occur during
induction of and emergence from general anesthesia (Specific Aim 1) and different stages of sleep (Specific
Aim 2). We will then leverage these biomarkers to understand mechanisms of delirium, which can occur in
neurosurgical patients during recovery from surgery and following seizures (Specific Aim 3).
Identifying biomarkers of consciousness has broad clinical relevance to development of novel algorithms for
monitoring depth of anesthesia. Knowledge gained from this project will contribute to improved diagnosis,
management and prognosis of pathologic states of consciousness including central sleep disorders, delirium,
vegetative or minimally conscious states, and coma.

Public health relevance
PROJECT NARRATIVE Defining neural signatures of distinct states of arousal and awareness is key to understanding the neural basis of consciousness. This proposal seeks to understand these mechanisms using intracranial electrophysiological recordings from human patients who undergo clinical evaluation for surgical remediation of their medically intractable epilepsy. Knowledge gained from this project will be of high impact for improvements in monitoring depth of anesthesia, and in the diagnosis, management and prognosis of pathological states of consciousness including central sleep disorders, delirium, vegetative or minimally conscious states, and coma.